Integrative Cancer Epigenomic Data Analysis Center (ICE-DAC)

PROJECT SUMMARY / ABSTRACT
The widespread nature of epigenetic abnormalities in human cancers has become increasingly appreciated
in the past decade, with clinical impacts in cancer detection, cancer classification, chemoresistance prediction,
and therapy. Large-scale cancer genomic screens have revealed a previously unrecognized prevalence of
somatic mutations among epigenetic regulators in human cancers, including chromatin remodelers, as well as
histone or DNA methylation readers, writers, and erasers. Epigenetic alterations can serve as driver events in
cancer by inactivating tumor-suppressor genes. The finding that these silencing events are mutually exclusive
with structural or mutational inactivation of the same gene reinforces the functional significance of epigenetic
silencing. The majority of cases of microsatellite instability in sporadic human tumors can be attributed to
epigenetic silencing of the MLH1 mismatch repair gene. Clearly, epigenetic mechanisms play a key role in
human cancer, and a comprehensive molecular characterization of cancer should include epigenomic profiling.
In 2015 we established an Integrative Cancer Epigenomic Data Analysis Center (ICE-DAC) to provide
specialized expertise in epigenomic data analysis as part of the Genome Data Analysis Network (GDAN). We
have made major contributions to the GDAN in the past five years, developing cutting-edge DNA methylation
bioinformatics tools, leading analysis teams in PanCanAtlas, ATAC-Seq, Pan-Gastrointestinal (Pan-GI)
Cancers and Tumor Molecular Pathology (TMP), and making major contributions to the Exceptional
Responders (ER) study, testicular germcell tumors (TGCT), data harmonization (QC), CCG Ancestry
Informative Markers (AIM), and many other projects. Here we propose to sustain this productive activity in a
continuation of the ICE-DAC, lending our deep expertise in epigenomic data analysis to collaborative,
integrative genomic and epigenomic analyses of clinical specimens within the NCI GDAN. In Specific Aim 1,
we will provide advanced specialized analysis of bulk and single-cell cancer epigenomic data generated by
programs within the NCI Center for Cancer Genomics. We have developed various tools for epigenetic
analysis and implemented an automated workflow to provide timely primary data analysis for AWGs. In
Specific Aim 2 we will implement innovative tools to extract additional information from specialized data types.
This Aim maximizes the utility of the data generated, and adds to the rigor of analysis by providing orthogonal
validation. These analyses will include prediction of common covariates (such as sex, age and race) for the
samples, analysis of tumor purity and composition, inferences of genetic information (including genetic
mutation, copy number and large structural variants), all from the DNA methylation assays. In Specific Aim 3
we will integrate epigenomic data with other genomic, transcriptomic, proteomic, and clinical data to derive
biologically and clinically relevant novel insights. Our deep expertise in specialized epigenomics will address a
core competency required in GDAN, and complement other genomic analyses of clinical trial samples.

Public health relevance
PROJECT NARRATIVE Cancer arises from the loss of control of growth in cells. Although attention has focused mostly on genetic mutations as the origin of these defects, it has become clear that changes in the epigenetic control of gene activity also contribute to this loss of growth control. This project aims to provide epigenetic analysis of clinical trial epigenomic data to advance our understanding of how epigenetic defects impact cancer biology and clinical outcome.